Administrative Core

The Administrative Core supports an environment of research excellence, scientific innovation,
and multidisciplinary scholarship within the Washington University Participant Engagement and
Cancer Genomic Sequencing (WU-PE-CGS) Center and across the NCI PE-CGS network. The
Core will use a matrix-style structure to foster excellence in management and communication.
Leaders and co-leaders of the three units in the Center along with patient representatives will
form the Leadership Committee, which will use a collaborative process to engage and maintain
the creativity and leadership of the significant individual and team expertise of the Center. The
Core will provide the structure for effective and efficient operation and maintenance of WU-PECGS in compliance with NIH and University guidelines, while leveraging innovative opportunities
to advance the field of participant engagement and cancer genomics. The Core will support the
overall mission of WU-PE-CGS through the following aims: (1) Organize the operational structure
and scientific leadership for all WU-PE-CGS components and provide oversight to maximize
efficiency, effectiveness, and accountability; (2) Build participant engagement for populations that
require more research to engage in network-driven collaborative studies via outreach among
other Centers in the network and collaboration with patient interest groups; (3) Provide scientific
leadership in low-resourced participant engagement and in genome sequencing among other
scientists in the network; (4) Evaluate all WU-PE-CGS activities and provide feedback to refine
ongoing activities; (5) Establish a timeline and milestones to monitor progress and coordinate
efforts. The Core will position WU-PE-CGS to optimize the innovation, pace, and impact of
participant engagement research and genomic characterization of rare cancers. WU-PE-CGS
investigators have substantial expertise and proven track records in conducting collaborative,
multidisciplinary science, including research programs in cancer control, genome sequencing,
dissemination of findings, and translating results for practitioners working in multiple settings. We
are uniquely situated to provide scientific leadership to connect and expand a network of cancerfocused participant engagement researchers; support innovation; and enhance capacity for
genome sequencing of rare cancers and those that require more research and directly interact
with patient interest groups and patients for return of results and ongoing participant engagement.
The Admin Core is a critical element of the overall scientific program and infrastructure of the
Center and provides a strong foundation for scholarly excellence, research synergy and
efficiency, and clinical and community impact of the Center during and beyond the funding period.